Tulane StARR Program

PROGRAM SUMMARY
This is the first renewal application for the Tulane StARR Program which successfully recruited a diverse cadre
of 6 StARR Scholars who are actively engaged in mentored research training in heart, lung, and blood (HLB)
diseases in the last 2.5 years. The long-term goal is to increase the number and diversity of highly trained,
independent, interdisciplinary board-certified physician scientists engaging in HLB research. Key components of
our successful mentored research and career development StARR program include: 1) Boot Camps and
didactics tailored to specific Scholar needs; 2) individualized career development training; 3) StARR Physician
Scientists seminar series; 4) Work-in-Progress sessions; 5) required grant writing, project management, and
mentoring workshops; 6) mentored interdisciplinary research; 7) responsible conduct in research training; 8)
institutional resources; and 9) a planned transition for StARR Scholars to fellowship training, K38, K12, or K-like
programs,. The innovative approach involves tailoring the program to Scholars needs using self-efficacy surveys
and individual development plans (IDP) and using a network mentoring model for each Scholar Oversight
Committee (SOC) which includes expertise in both basic and clinical science and clinical care, as well as
participation by the Residency Program Director to ensure appropriate integration of clinical and research
rotations. Scholars are immediately exposed to research, are guided to establish a scholarly track record early,
and participate in national scientific meetings. New components of Tulane StARR 2 include expanding capacity
by increasing faculty Preceptors and Tulane Research Centers in expanded fields of HLB; building Scholar
competence in team science and equity, diversity, and inclusion (EDI) in research; and advancing understanding
of the interplay between HLB with social determinants of health (SDOH).The Scholars will learn cutting-edge
research methods and skills from Bench (cellular, molecular, and genetics), to Bedside (clinical research and
clinical trials) to Population (epidemiology, prevention, and implementation research) and conduct mentored
research projects in established laboratories/research groups led by 52 outstanding NIH-funded Preceptors in a
mentored, interdisciplinary environment that addresses NHLBI priorities from a lifespan perspective. With strong
institutional support and approval of the training by the American Board of Internal Medicine and American Board
of Pediatrics, we propose to train 8 (6 new, 2 carryover from Tulane StARR 1) resident StARR Scholars (4
medicine residents and 4 pediatric residents; 50% women and 25% underrepresented groups (URG)) for 18
months (in 6-month Research Blocks in PGY 2, PGY3, and PGY4 with 80% effort dedicated to research) over
the 4-year residency program while maintaining Continuity Clinics. Ongoing and comprehensive evaluation will
assess and guide improvements to the StARR Program’s effectiveness in 1) bridging research training and
research independence; 2) ensuring board eligibility for medicine and pediatrics residents; and 3) increasing the
number and diversity of physician scientists translating science to improve human health across the lifespan.

Public health relevance
PROGRAM NARRATIVE There is a pressing need for a diverse workforce of physician scientists who have the skillsets to conduct rigorous interdisciplinary scientific research and develop novel approaches for improving diagnosis and treatment of human disease. To this end, the Tulane StARR program will provide a mentored research and career development program for medicine and pediatric residents to increase the number and diversity of highly trained physician scientists in heart, lung, and blood diseases research. The program engages outstanding preceptors with established track records of mentoring and conducting highly meritorious research, and will foster the next generation of physician scientists able to make discoveries and translate discoveries into improved human health.